Biospecimen Processing and Storage Core

PROJECT SUMMARY Biospecimen Processing and Storage Core (Core B)
The proposed cancer health disparities translational research program in this P20 planning grant
application relies on the submission of serial peripheral blood, bone marrow and cerebrospinal fluid (CSF)
specimens from children and adolescents with acute lymphoblastic leukemia (ALL) across the
participating clinical recruitment sites of the Reducing Ethnic Disparities in Acute Leukemia (REDIAL)
Consortium. The Biospecimen Processing and Storage Core (BPSC) will serve as the central location
where these samples will be processed into the materials needed for the specific studies in Research
Projects 1 (treatment-associated hepatotoxicity) and 2 (methotrexate neurotoxicity), as well as
determination of genetic ancestry for use across all projects, and biobanking of material that will be
available for pilot projects through the Developmental Research Program (DRP). This Core will support
the collection, shipping, processing, and storage of patient samples from each study site, as well as
provide up-to-date and accurate sample annotation. The Core will follow previously developed standard
operating procedures to ensure uniform collection and processing for optimal sample yield and quality.
The Aims of the Core are to: 1) Receive and catalog blood, bone marrow and CSF provided by the
Consortium sites; 2) Process all patient samples to isolate plasma, peripheral blood mononuclear cells,
and bone marrow mononuclear cells, and separate blasts from non-blasts where appropriate; 3) Allocate
and distribute samples to Projects; and 4) Maintain a biobank of samples for future research. The resulting
biobank will become an extremely valuable resource for this and future translational studies examining
ethnic disparities in childhood ALL.

Public health relevance
NARRATIVE Biospecimen Processing and Storage Core (Core B) Latino children with acute lymphoblastic leukemia (ALL) have a higher frequency of treatment-related toxicities compared to other racial/ethnic groups. Multiple factors likely contribute to these disparities in this vulnerable population of children, including underlying germline genetics, tumor biology, and social determinants of health. The Biospecimen Processing and Storage Core will serve as the central location where biospecimens will be processed and stored to support research that can provide insights into the biological factors underlying ethnic cancer health disparities in childhood ALL.